TASK A110: DEVELOPMENT OF THE RAT ANIMAL MODEL FOR PNEUMONIC TULAREMIA

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.